Dehydroamino acids in HIV-1 capsid and matrix proteins: new potential targets for viral inactivation

Project Summary/Abstract
We have recently discovered dehydroamino acids (DHAAs) in the capsid and matrix proteins that make up
HIV-1 virions. These dehydroalanine (DHA) and dehydrobutyrine (DHB) residues result from posttranslational
modification of serine, threonine, or cysteine residues. We propose here to investigate the importance and
origin of these fascinating protein modifications. Their high prevalence in these viral proteins, in marked
contrast to their low levels in the human proteome generally, raises two key questions: a) why are they there?
and b) how did they get there? We hypothesize that DHAAs are present in virions because they play important
roles in the HIV virion assembly or capsid maturation. We hypothesize further that DHAAs are formed by a
presently unknown enzymatic activity in viral or host proteins.
To test these hypotheses, we will conduct mutation and inactivation studies of the amino acids that convert to
dehydroamino acids and study the effects on the viral replication cycle and infectivity. We will use quantitative
proteomics to determine how much of this modification is generated and whether it is before or after viral
maturation. We will seek to discover intra- or intermolecular protein crosslinks, which dehydroamino acids are
known to be able to form, using innovative proteomics approaches. Further, we will seek to discover the
enzyme responsible for the formation of these modifications. The discovery of the enzyme responsible for
DHAA formation would be interesting as fundamental biology, offer new insights into HIV replication, and
potentially reveal a new therapeutic pathway for the treatment of HIV infection.

Public health relevance
Project Narrative We propose to investigate the importance and origin of a fascinating modification that we recently discovered to the HIV structural proteins, namely the formation of dehydroamino acids. HIV is the virus that causes AIDS and infects over 1 million people each year. We will examine the role of these modifications in the HIV life cycle and evaluate their purpose. Further, we will test the hypothesis that they are formed enzymatically, and if so, discover the enzyme responsible. This may provide an exciting new pathway for the development of antiretroviral therapeutics. In 2020, over 37 million people, including 1.7 million children, were living with the virus, and over 500,000 died from AIDS. For a robust eradication of the virus, additional research such as the work proposed here is desperately needed to eliminate knowledge gaps in our understanding of viral infection and replication.